COLLABORATIVE INFLUENZA VACCINE INNOVATION CENTER: CLINICAL CORE

To design, implement and manage a Phase I clinical trial to advance research on a universal influenza vaccine developed by the NIAID Collaborative Influenza Vaccine Innovation Centers.